Molecular & Translational Immunotechnology Core

Core E: Molecular and Translational Immunotechnology Core
ABSTRACT
The Penn CFAR Molecular and Translational Immunotechnology Core (MTIC, Core E) provides Advanced
Technology through services, equipment, expertise, consultation, training, and other types of support to catalyze
cutting-edge research on the Penn CFAR campus and beyond, to advance immune-focused studies in HIV-1
pathogenesis, vaccines, cellular therapy, cure and other areas of high priority to the national and NIH AIDS
research agenda. Under the direction of Drs. Jim Riley (Director) and Nina Luning Prak (Co-Director), the
Core ensures that Penn CFAR investigators have access to emerging or highly specialized enabling
technologies that lead the research agenda, as well as an array of other services that offer unique methodology,
resources or economy of scale.
Leveraging an interdisciplinary team of expert immunologists, laboratorians, computational biologists and
physician scientists, the MTIC aims to: (1) Develop and perform technologically advanced immunologic assays
and sophisticated data analysis services to enable basic and translational investigations in HIV; (2) Provide
large-volume, highly purified primary human immune cells of multiple subsets, and quality controlled human
sample processing to support research, including complex innovative clinical trials and (3) Provide mentoring,
training and outreach to expand and advance the community of HIV investigators. In the current funding cycle,
MTIC supported 33 Penn CFAR investigators and 5 non-CFAR Philadelphia AIDS investigators, generated
$1,675,000 of chargebacks, supported over 86 NIH-funded applications, and our services have contributed to
165 publications.
In the upcoming cycle, we will provide innovative services and products, receiving input on the composition,
development, and delivery of these services from Core clients via extensive interactions with the HIV research
community through scientific consultations, meetings, and mentoring sessions. In collaboration with the Clinical
Core (Core C) and Virus & Reservoirs Technology Core (Core D), MTIC/Core E will provide additional support
to the HIV Single Cell Reservoirs & Immunology SWG by expanding our primary cell purification services for
latent reservoir studies and integration of immune repertoire profiling with single cell multi-omics and virus
evolution studies. Furthermore, with the Clinical Core, Virus & Reservoirs Technology Core and BEAT HIV
Delaney Collaboratory, MITC/Core E will contribute products, services and expertise for several large HIV
Cure-focused clinical studies that will help lead the field in how to best engage the immune system to promote
HIV remission in the absence of ART.